Regulation and Mechanisms of Transitional Epithelial Cell Senescence in Lung Fibrosis

Project Summary/Abstract
This proposal outlines a two-year research training plan to provide the applicant the technical skills, experience
with both in vivo and in vitro models, and analytic skills necessary for earning a K08 award on alveolar
epithelial repair mechanisms and fibrotic responses following lung injury.
Research Plan: Interstitial lung diseases such as idiopathic pulmonary fibrosis (IPF) remain a major source of
morbidity and mortality worldwide, and available therapies are limited in their efficacy - despite decades of
research, clinical management revolves around supportive care, avoidance of further injurious stimuli, and lung
transplantation in select cases. Our lab made the seminal discovery that after injury, progenitor cells proliferate
and pass through a distinct transitional cell state during regeneration of alveolar type 1 (AT1) cells. This state is
transient during physiologic regeneration but appears to persist in non-resolving injury, suggesting that
persistence of the transitional state may be a key defect contributing to disordered repair and fibrosis. This
transitional state activates TGF-β signaling pathways known to be involved in IPF pathogenesis and exhibits
markers of cellular senescence. Senescence is a state of cell cycle arrest which has been strongly implicated
in the pathogenesis of IPF and other fibrotic lung diseases. However, the mechanisms by which these
transitional cells acquire senescence remain unknown. Cellular communication network factor 1 (CCN1, also
known as Cyr61) is a secreted matricellular protein that is highly upregulated in the transitional state and
known to mediate senescence in other tissues. Some evidence suggests that its function is profibrotic in lung
injury. However, the mechanisms that regulate its expression in transitional epithelial cells and by which it
promotes fibrosis are unknown. This proposal seeks to examine the effects of CCN1 on transitional state
senescence and the regulation of CCN1 by TGF-β signaling. I hypothesize that in the transitional state, CCN1
is driven by TGF-β signaling and promotes transitional cell senescence. In Aim 1, we will assess whether
CCN1 induces senescence using murine models of bleomycin-induced lung injury. To test this in vivo, we will
use RNA interference-based and genetic strategies to knock down CCN1 in lung epithelial cells. In vitro, we
will use primary murine alveolar type 2 (AT2) cell culture assays to understand the mechanisms by which
CCN1 affects transitional cell senescence. In Aim 2, we will inhibit TGF-β signaling by multiple methods in vitro
to understand whether and how CCN1 expression is regulated by canonical TGF-β signaling. We will validate
our findings in vivo using TGF-β receptor loss-of-function in the bleomycin model. We will validate key in vitro
experiments in both aims in human induced pluripotent stem cell (iPSC)-derived AT2 cells and in fixed tissue
from IPF patients.

Public health relevance
Project Narrative Idiopathic pulmonary fibrosis remains a major cause of morbidity and mortality worldwide, and available therapies are limited in their efficacy. Fibrotic scar arises due to disordered or ineffective repair after injury, however we do not understand why some lungs scar after injury and some lungs heal normally. This project seeks to better understand the mechanisms of lung repair in response to injury to develop more effective therapies.